2/2- Randomized comparison of the Outcomes of single vs Multiple Arterial grafts trial in Women (ROMA:Women)

Project Summary / Abstract
Coronary artery bypass grafting (CABG) is the most common adult cardiac surgery procedure, and the standard
of care for patients with severe coronary artery disease. CABG can be performed using either arterial or venous
grafts, with arterial grafts being associated with better outcomes in observational studies, but not in the only
published randomized trial. Women represent a minority of patients in CABG trials, and there are important
biological and surgical differences between men and women undergoing CABG ROMA:Women is the first trial
comparing arterial vs. venous graft in a exclusive women population.
In a rigorous randomized trial that focus enrollment exclusively in women we will determine 1) the impact of
MAG vs SAG on major adverse cardiac and cerebrovascular events in women undergoing CABG and 2) the
impact of MAG vs SAG on generic and disease- specific quality of life (QOL) as well as physical and mental
health symptoms in women undergoing CABG. We will enroll 2,000 women randomized 1:1 to MAG or SAG.
ROMA:Women will leverage the existing infrastructure of ROMA (conducted on both Women and Men) including
the clinical trial database, case report forms, randomization system, site training resources, regulatory approvals,
network of participating sites, and study coordinators. The trial primary outcome will be a composite of death,
stroke, non-procedural myocardial infarction, repeat revascularization and hospital readmission for acute
coronary syndrome or heart failure at a minimum follow-up of 2.5 years. The secondary outcome will be the
absolute changes in the Seattle Angina Questionnaire (SAQ) at 12 months compared to baseline. The trial is
designed to have >90% power to demonstrate a 25% relative risk reduction in the primary composite outcome
in the MAG group. Generic QOL (SF-12, EQ-5D), and symptoms (PROMIS-29) as well as key clinical events will
also be captured.

Public health relevance
Project Narrative Women receive significantly fewer arterial grafts compared to men, in part due to the limited available evidence to support its clinical benefits. The results of R OMA:Women will inform the use of multiple arterial grafts in women and have the potential to change clinical practice guidelines. The trial will improve the clinical and patient-reported outcomes of women undergoing coronary bypass surgery worldwide.